DNA repair pathway coordination during damage processing

Project Summary/Abstract
UV light, carcinogen exposure from air pollution and other environmental agents can damage DNA.
The resulting base damages, if not properly processed and removed, can lead to DNA mutations,
causing cell death or cellular transformation manifested in a wide variety of human maladies including
aging, cancer, and neurodegenerative diseases. While canonically UV-damage and oxidative
damage are repaired by nucleotide excision repair (NER) and base excision repair (BER),
respectively, recent work indicates that key damage sensor proteins are not siloed within one repair
pathway but work cooperatively in both BER and NER: these include poly(ADP-ribose) polymerase 1
(PARP1) (10-17), UV-damaged DNA binding protein (UV-DDB; a heterodimer of DDB1/DDB2) (18-
20), and xeroderma pigmentosum complementation group C protein (XPC-RAD23B). I hypothesize
that key damage sensor proteins work together on multiple forms of damage to facilitate BER and
NER, that handoff mechanisms depend on the type of DNA damage, and that handoff is essential to
process damage embedded within nucleosomes. This hypothesis will be tested with single molecule
and cell biology experiments with the completion of the following aims: AIM 1: To determine how
DNA damage sensors cooperate at UV photoproducts. In subaim 1a, DNA binding positions,
binding lifetimes, and mean squared displacement (for motile events that slide on the DNA) will be
analyzed for UV-DDB, XPC-RAD23B, and PARP1 on UV photoproducts. Subaim 1b will investigate
the kinetics of lesion hand-off for these three proteins by studying them in pairs (at equal
concentrations) using orthogonal labels. In subaim 1c, the binding parameters of these three proteins
will be assessed on nucleosomes with damaged DNA, with the proteins analyzed alone or with
relevant nucleosome interacting proteins (HPF1 for PARP1 and Cullin-4A/RBX for UV-DDB). AIM 2:
To define DNA damage processing and handoff at oxidative lesions including single strand
breaks and 8-oxoG. Subaim 2a will study the interactions of PARP1, XPC-RAD23B, and UV-DDB on
8-oxoG and single-strand breaks at the single-molecule level. Each protein will be examined
individually and in pairs for each damaged substrate. Subaim 2b will measure the binding dynamics
for each protein for nucleosomes with 8-oxoG and single-strand breaks positioned at three different
sites. Subaim 2c will study 8-oxoG introduced specifically into the chromatinized DNA of living cells
utilizing a novel chemoptogenetic system (18, 20, 27). Chromatin remodelers associated with
decompaction at damage sites will be knocked down and the repair kinetics will be studied for
damage sensor proteins, 8-oxoguanine glycosylase, and other downstream repair proteins.

Public health relevance
Project Narrative Various environmental sources, including exposure to UV light and pollution, relentlessly damage DNA, causing numerous human maladies including neurogenerative diseases and cancer. In this fellowship, I will characterize how three key DNA damage sensors work together to find and handoff oxidative and UV damage in the context of naked DNA and chromatin. By better understanding how repair pathways interact together to fix damage, this work will provide meaningful information maladies related to these environmental exposures can be prevented and treated.